Identification of Distinct Multimodal Biotypes of PTSD Using Data Driven Approach: A Multisite Big Data Study

Posttraumatic stress disorder (PTSD) is a highly prevalent and debilitating disorder. Despite efforts to
characterize the pathophysiology of PTSD and its heterogenity, no objective biomarker have been established
to aid in diagnosis, and prediction of treatment response. This K01 presents a program for research and training
that will support the applicant on a path towards becoming an independent investigator, focused on utilizing a
data-driven computational approach and machine learning techniques to identify multimodal neural biomarkers
of PTSD (supervised) and multimodal biotypes of PTSD (unsupervised) and explore whether such biotypes could
be used to predict response to prolonged exposure (PE), the first line treatment for PTSD. The training plan
builds on the candidate’s prior training and experience and capitalizes on a mentorship team and a research
environment to foster development of the candidate’s expertise in 1) the neural and behavioral basis of PTSD
and anxiety disorders; 2) multimodal data fusion analysis and latent dimension interpretation with data-driven
computational approaches and data reproducibility; and 3) patient-oriented translational research in anxiety
disorders. This research project will apply both supervised and unsupervised machine learning techniques on
multimodal MRI data from the largest existing PTSD dataset (N~3000 from the ENIGMA-PTSD working group).
Biotypes identified from this large dataset will then be extended to clinical treatment data. The results of the
proposed research will be vital to aid in finding neural biomarkers of PTSD and better predict different treatment
outcomes through different biotype targets and will lead to a future R01 grant examining brain-symptoms
association across anxiety and trauma-related disorders, and to use the newly identified PTSD biotypes to inform
different treatment outcomes in a following R61/33. Together, the research and training experiences and
expertise developed through this K01 award will support the applicant’s transition to research independence and
ensure the applicant becomes a leading authority in the application of data-driven computational approaches in
psychiatry research, and provide the basis for future NIMH grants to explore biotypes from multimodal brain
imaging using data-driven computational approaches across anxiety-related disorders.

Public health relevance
PTSD can occur after a direct or indirect traumatic experience and is a highly prevalent and debilitating disorder. This research project use a big data and data-driven approaches to study the heterogenity of PTSD. In the long term, this line of research will aid in finding neural biomarkers of PTSD and better predict different treatment outcomes through different biotype targets, which will advance the development of effective diagnostics and treatments for PTSD.